SR Flow Cytometry

PROJECT SUMMARY (See instructions): The Flow Cytometry Core facility is dedicated to advancing research projects requiring cell sorting and/or analysis of cell populations by flow cytometry. The core offers training on and access to shared use instrumentation for analytical flow cytometry, services for fluorescence activated cell sorting (FACS) as well as technical consultation and support on experimental design, execution, and data analysis. All CCSG supported core are organized into one group: Basic Research. This shared resource is categorized as category (1.18) Flow Cytometry in summary ID.

Public health relevance
RELEVANCE (See instructions): Analysis of individual cells enables understanding of the changes that affect whole populations of cells. This resource will enable this analysis, and help to purify subsets of cells for further study.